TAPPING SPEED IN NORMAL SUBJECTS--AGE AND CIRCADIAN INFLUENCES

We will measure tapping rates in up to 200 normal outpatients to estimate the distribution of tapping rates in the normal adult polulation. Some subjects will be tested every 4 months to 12 months for up to 10 years to determine if the rates change with time. A subset admitted to the General Clinical Research Center (GCRC) will have hourly tapping rates measured to examine circadian variation in tapping speed.